Understanding MORF-mediated hematological gene regulatory mechanisms

Project Summary
The monocytic leukemia zinc-finger protein-related factor MORF is a transcriptional coactivator
and a catalytic subunit of the histone acetyltransferase MORF (named after its catalytic subunit)
complex. MORF regulates expression of hematologic, cardiac and developmental genes and
plays a pivotal role in the development of the hematopoietic system and the formation of blood
cells. Aberrant acetyltransferase activity of MORF is linked to aggressive forms of leukemia, blood
diseases and cardiovascular abnormalities. The MORF driven epigenetic mechanisms in the
normal and disease states remain poorly understood, and characterization of these mechanisms
may pave the way for the development of novel strategies to diagnose, prevent or treat these
diseases. Our preliminary data indicate a multivalent engagement of MORF with chromatin
through its histone and DNA binding domains that regulate enzymatic activity and genomic
localization of the complex. The molecular basis underlying novel functions of MORF and
biological consequences are unknown and will be determined in the proposed studies. The results
generated in this work will offer a comprehensive understanding of the molecular mechanisms by
which the MORF subunit is bound to specific genomic sites and its enzymatic activity is regulated,
provide atomic-resolution insight into MORF signaling pathways that may constitute new targets
for therapeutic interventions, aid in our understanding of the etiology of hematological and
cardiovascular diseases associated with aberrant MORF activity, and enhance our knowledge of
the fundamental principles underlying the ‘epigenetic code’ writing and recognition.

Public health relevance
Project Narrative MORF plays a key role in mediating hematologic and developmental gene expression, and aberrant MORF activity is linked to leukemia and blood diseases. This work will lead to a better understanding of how MORF-dependent signaling pathways can be therapeutically manipulated and may help to develop new tools and approaches to diagnose, prevent or treat these diseases.